Rcor1 Regulates Myelomonocytic Progenitor Cell Fate

Project Summary Understanding the molecular mechanisms that govern hematopoietic lineage specification and differentiation is critical for developing targeted therapies for bone marrow failure and myeloproliferative disorders. Rcor1 (CoREST) is an established cofactor for the histone demethylase LSD1/KDM1, however its role in regulating hematopoiesis is unknown. Using a conditional knockout model we now demonstrate that myeloerythroid differentiation is profoundly dependent on Rcor1. The overall goal of this proposal is to the identify the mechanisms by which Rcor1 regulates myelomonocytic progenitors. Specifically we will i) Determine the functions of Rcor1 in myelomonocytic progenitors and monocytes; ii) Identify Rcor1 targets in granulocyte precursors and monocytes and iii) Determine the functions of the Rcor1 target genes and pathways in myelomonocytic progenitor cell differentiation. By profiling the transcriptional programs in Rcor1 deficient progenitors, we will identify functionally relevant transcriptional targets of Rcor1. The results of this study will contribute to our understanding of epigenetic regulation of normal hematopoietic progenitor cells and will likely provide important insights relevant to the pathogenesis of bone marrow failure syndromes and myeloproliferative disorders.

Public health relevance
Project Narrative Although increasing evidence indicates that epigenetic changes cause a variety of blood diseases including bone marrow failure syndromes and myeloproliferative disorders, the molecular mechanisms responsible are largely unknown. We have recently discovered that the depletion of Rcor1, an epigenetic modifier, results in a profound defect in neutrophil maturation and the over production of monocytes. The goal of our proposal is to identify Rcor1 targets that can be used to restore the normal differentiation program of myelomonocytic progenitor cells.